Leveraging research and clinical cohorts to improve Obstructive Sleep Apnea subtyping

Obstructive Sleep Apnea (OSA), characterized by recurrent pharyngeal obstructive events during sleep, affects
as many as 38% of adults, most of whom are not diagnosed and treated, and thus at potential risk for daytime
impairment and long-term health problems. Efforts to implement evidence-based approaches for improving
diagnosis and treatment have been impeded by the lack of data from longitudinal studies and clinical trials that
address which patients are at greatest risk for cardiovascular disease and other health problems, and who is
most likely to benefit from intervention. Notably, the standard disease-defining metric, the Apnea Hypopnea
Index (AHI), the number of breathing pauses during sleep, does not characterize the heterogeneity of OSA
mechanisms, the physiological impact of the breathing disturbances, risk for adverse outcomes, and likelihood
of responding to treatment. Our multi-disciplinary team will address this gap by integrating multiple data sources
to derive physiologically informative individual and composite metrics of OSA and characterize their associations
with mechanistic traits, symptoms, risk factors, molecular markers, and clinical outcomes. We will cost-effectively
utilize data from: a) existing large prospective research cohorts (including data within the National Sleep
Research Resource and Trans-Omics in Precision Medicine; n≈29,000; b) newly ingested sleep and clinical
outcome data from a large clinical biobank; n≈30,000; and c) a prospective study of patients with OSA recruited
to examine the short-term reproducibility of OSA metrics. In Aim1, we will quantify the reproducibility of OSA
severity markers (i.e., that quantify ventilatory reduction and hypoxia, heart rate, and sleep fragmentation
responses to obstructive events) in a diverse sample of patients with a range of AHI studied twice over ≈ 2 weeks
with polysomnography. Using the most reproducible metrics, we will derive OSA composites that are potentially
more informative than individual metrics and describe OSA subtypes. In Aim 2, we aim to further characterize
the clinical and physiological heterogeneity of individual OSA metrics and composites by describing their
associations with symptoms and socio-demographic, health-related, metabolomic, and endotypic markers. We
will use genetic instruments and Mendelian Randomization to study associations of OSA metrics/composites
with each other and with common co-morbidities (e.g., obesity, diabetes, hypertension, etc) and candidate
biological pathways (inflammation, lung function, etc) - clarifying which associations reflect shared genetics,
indirect effects, and/or direct causal effects. In Aim 3, we will use existing longitudinal and clinical trial data to
evaluate which OSA metrics/composites predict long term health outcomes and OSA treatment response.
Scalability will be addressed by identifying parsimonious sets of metrics that can be most readily incorporated
into clinical practice. With professional society and patient input, we will develop and disseminate a foundational
OSA classification (taxonomy), annotated for relevance by sex and social determinants of health, with the goal
of improving the understanding of the heterogeneity of OSA, providing a foundation for OSA precision medicine.

Public health relevance
PROJECT NARRATIVE Sleep apnea is a common disorder associated with many adverse health outcomes, but often unrecognized and under-treated. The usual measure of disease severity, the Apnea Hypopnea Index, does not adequately characterize disease subtypes reflective of differences in underlying mechanistic risk factors, and thus poorly predicts which patients are most susceptible to adverse health outcomes and would benefit from treatment. This study will systematically identify new measures of sleep apnea that reflect differences in disease severity and mechanisms and allow subgroups of patients to be better characterized, facilitating identification of the most appropriate patients for enrollment into clinical trials and receipt of sleep apnea therapies.